TAS::75 0872::TAS PROTEOMICS OF INFLAMMATION, IMNUNITY AND PULMONARY ARTERIAL HY

The goal of the Stanford University Proteomics Center is to explore and converge results from different, innovative platform technologies that analyze intracellular and secreted proteins related to pulmonary arterial hypertension (PAH). One of the main features of the proposal is the development of relational software and application of statistical analysis regimens that will allow the integration, comparison and correlation of different datasets generated by the different technologies.